Administrative Core

CORE A SUMMARY/DESCRIPTION
Core A is critical to the operation of this program project, and has three major aims. In Aim 1, core A will initiate
and organize regular communication between the principle investigators and personnel for each project and
research service core, with a goal to ensure each program element appropriately prioritizes and efficiently
completes high-impact research. In Aim 2, Core A will ensure advisory boards provide sufficient program
oversight, both with respect to scientific activities, as well as ensuring the program follows NIH mandated policy
on scientific research. In Aim 3, Core A will provide organization and logistical support for the program, including
the administration of all fiscal resources.

Public health relevance
CORE A NARRATIVE This core will provide the administrative management of the Program, plans for monitoring of progress, and plans for effective coordination and communication within the Program. The administrative core is especially critical to this program project to ensure that the scientific Cores and Projects are communicating and collaborating seamlessly and effectively within the NYU Langone Health community.